Linking an activity-dependent BMP pathway to synapse structure and function

Project Summary The Landis Award administrative supplement will be used to support current and future trainees in the Broihier lab in their studies of molecular mechanisms of synapse organization. In part, it will be utilized to support their attendance at scientific conferences which will provide them with valuable experience presenting their work to a scientific audience. It will further support their utilization of specialty scientific cores on campus, including the high resolution microscopy core. Together, these activities will have significant positive impact on their training experience.

Public health relevance
Project Narrative The Landis Award administrative supplement will enable us to provide key support to enrich the training experience of current and future trainees in our studies of neurodevelopmental disorders.